HIGH VS LOW DOSE OF DDI IN CHILDREN WITH SYMPTOMATIC HIV INFECTION

This salvage protocol offers ddI as an alternative to AZT for children who did not tolerate AZT due to toxicity or who have progressive disease or both despite at least 6 months of AZT.